Blood Expression Profiles as a Biomarker for Responses to Tuberculosis Treatment

DESCRIPTION (provided by applicant): This study aims to: (1) develop new markers for response to tuberculosis (TB) treatment through expression profiling or analysis of patterns of RNA expression in human blood as quantified by microarray technology and (2) determine whether small regulatory RNA (sRNA) secreted by M tuberculosis act to suppress expression of host-protective genes in macrophages through RNA interference (RNAi). New markers for response to TB treatment. Specific disease states may produce signature RNA patterns not seen in other conditions and the pathogen-specific component of human expression may distinguish between infections. Identifying expression that is specific to TB requires a clinically-relevant comparison group. To avoid over-estimating test accuracy, biomarkers should be developed in the patients likely to be tested in practice with an intention-to-test approach. The first step of this project will identify and validate a TB expression panel by comparison with patients with community-acquired pneumonia (CAP) in cohorts of subjects in the U.S. and Uganda. The second step will test whether expression of the TB panel in blood resolves with successful treatment of active TB. We hypothesize that expression of genes in the TB panel will change to resemble expression in controls without pneumonia, reflecting resolving immune response as bacillary burden decreases. Finally, it is unclear whether blood is a surrogate for understanding TB-specific responses in the lung. Although blood expression may identify effective biomarkers even without recapitulating lung expression, interpretation of the pathobiological significance of blood expression demands understanding the relationship between blood and lung expression. To determine the extent to which TB-specific expression in blood reflects inflammatory pathways in the lung this study will compare expression in simultaneously collected blood and BAL while adjusting for the different cell types present in each specimen type. sRNA secreted by Mtb may subvert host-protective macrophage responses via RNAi. RNAi, the biological process in which endogenous non-coding sRNA molecules bind mRNA and inhibit gene expression, is a fundamental regulatory mechanism in both Mtb and humans. sRNA secreted by Mtb was recently shown to increase bacterial viability in macrophages. We hypothesize that the mechanism for this increased viability is Mtb-derived sRNA silencing of expression of important human host-protective genes. Specifically, through RNA sequencing we have identified Mtb-derived sRNA which are predicted to bind the 3' untranslated region of key host-protective human mRNA transcripts for IkB?, TRAF-3 and TRAF-5. We propose to validate this novel form of cross-species RNAi. If confirmed, this would represent a novel form of host-pathogen interaction that could offer new targets for anti-TB therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tuberculosis (TB) is an important health concern for current service members and veterans because service in conflict zones can cause TB exposures. For example, rates of TB in Iraq and Afghanistan are 16- and 45-fold higher than in the U.S., respectively, and management of TB risk is a major challenge for military public health. The global emergence of drug-resistant forms of TB makes this risk even greater. Military occupational exposures are a CSR&D priority research area. This proposal aims to develop new biomarkers for TB which would enhance veteran health for several reasons. New TB drugs are urgently needed to shorten treatment and treat drug resistance but clinical trials are held back by lack of an early marker for treatment failure. A new marker would change the clinical trial landscape and could also be used to monitor individual patients. An additional aim is validating a new form of host-pathogen interaction through RNA interference. If confirmed, this mechanism could provide new targets for therapy.